Expanding the Facets of Multi-Functional Antioxidant Molecules Through Computational Design and Biological Tools

Project Summary
Chronic oxidative stress is a challenge to human health, being a major player in chronic and devastating diseases
and disorders including but not limited to Alzheimer’s, macular degeneration, kidney disease, Friedreich’s ataxia,
cancer, and inflammatory bowel syndrome. Yet, we approach treatment of each disease differently despite a
common pathology throughout (oxidative stress). The objective of this proposal is to show that small molecules
achieve control of oxidative stress and prevent damage to cells, lipids and other macromolecular structures
through multiple, catalytically driven pathways. Broadly, the demonstration that control of oxidative stress is a
viable approach to prevent or halt disease would result in improved strategies resulting in more positive patient
outcomes long-term.
The investigators have developed a class of small molecules that exhibit significant antioxidant reactivity in
biological assays through two mechanisms: direct reactivity with reactive oxygen species and catalytic
detoxification of those species. The catalytic reactivities observed are multi-fold: (1) Activate the Nrf2
transcription pathway that generates a plethora of antioxidant enzymes, (2) Highly stable metal complexes are
mimics of superoxide dismutase and catalase, and (3) (based on preliminary data) anti-ferroptotic. Our goal for
this project is to demonstrate that the multifaceted reactivities of these molecules is controllable and predictable.
The investigators will incorporate virtual screening, synthetic chemistry, and molecular biology methods to
produce enhanced antioxidant small molecules and understand how the small molecules activate catalytic
antioxidant reactivities. Specifically, a new virtual screening workflow based on recent advances in computation
will be used to identify the most promising targets from a library of >10,000 molecules. Following synthesis of
these targets, cellular models for neurodegenerative and ocular diseases will be used to test for protection from
oxidative stress. Molecules that show protection will be evaluated for Nrf2 activation by measuring the levels of
downstream genes including NQO1 and HO-1 using qPCR and western blot analysis, for example. Biomimetic
activity will first be measured in benchtop assays and then transferred to cell models. Lastly, markers for
ferroptosis will be evaluated for anti-ferroptotic activity resulting from iron binding. Molecules showing potent
antioxidant activity will also be screened for metabolic stability and blood brain barrier permeability. This
approach will identify the path(s) of protection, physiochemical properties related to drug-like behavior
and, identify lead molecules to be explored further and proceed to future work involving animal toxicology,
clearance, and activity assessment.

Public health relevance
Narrative The project will produce small molecules that can re-balance reactive oxygen species through multiple, efficient pathways. These molecules will be identified by the new computational workflows that can predict the behavior of macrocyclic molecules in solution. The results from this project will pivot the direction of understanding how small molecules can serve as therapeutics for disease.